Mechanisms and Relevance of Sodium Transport Regulation by AMPK

DESCRIPTION (provided by applicant): Proper function of the epithelial Na+ channel (ENaC), the rate-limiting step for Na+ reabsorption in the distal nephron, is critical to the regulation of body volume status and blood pressure. Recent work has established that the metabolic sensor AMP-activated protein kinase (AMPK) inhibits the activity of ENaC and other important epithelial transport proteins, which appears to provide a sensitive coupling mechanism between ion transport and cellular metabolic status and helps conserve cellular energy under conditions of metabolic depletion during ischemic tissue injury. AMPK inhibits ENaC by decreasing its expression at the apical membrane via enhanced endocytosis and channel ubiquitination through increased ENaC interaction with Nedd4-2, an E3 ubiquitin ligase that has emerged as a central convergence point for ENaC regulation. However, the mechanistic details of this regulation and role of AMPK in the ischemia-induced inhibition of ENaC and other transport proteins in vivo are unclear. Preliminary data indicate that AMPK directly phosphorylates Nedd4-2 at a site that appears to be critical for cellular Nedd4-2 stability. Additional preliminary data suggest that the Rho-GEF signaling protein β1Pix, which inhibits ENaC by impairing 14-3-3 ? binding to Nedd4-2 and promoting Nedd4-2 inhibition of ENaC, is phosphorylated by AMPK and required for the AMPK- dependent inhibition of ENaC. We thus hypothesize that AMPK exerts two effects on Nedd4-2 to enhance its interaction with and inhibition of ENaC: (1) direct Nedd4-2 phosphorylation by AMPK, which enhances Nedd4-2 stability; and (2) AMPK phosphorylation of β1Pix, which enhances Nedd4-2 association with ENaC by competing with Nedd4-2 for 14-3-3 ? interaction. Further preliminary data suggest that AMPK contributes to the acute inhibition of ENaC with chemical ischemia in polarized cortical collecting duct cells and that ENaC is upregulated in the kidney in vivo in AMPK- α1 knockout mice with largely kidney-specific loss of AMPK function. We thus hypothesize that AMPK regulation of ENaC is relevant in vivo and that AMPK activation plays an important role in Na+ transport inhibition following renal ischemic injury in vivo. To evaluate the mechanisms of AMPK-dependent ENaC regulation via Nedd4-2 and test its role in ischemic kidney injury in vivo, the Specific Aims of this project are to: (1) examine the role of Nedd4-2 phosphorylation by AMPK in the AMPK-dependent regulation of ENaC and Nedd4-2 cellular stability; (2) examine the role of AMPK phosphorylation of β1Pix in the regulation of ENaC; and (3) examine the role of AMPK in the down-regulation of ENaC in vivo in response to acute ischemic kidney injury using AMPK- α1 knockout mice and wild-type littermates. The proposed studies should promote our understanding of the Nedd4-2-dependent regulation of ENaC and other Nedd4-2-regulated transport proteins by AMPK, of the role of AMPK in transport-metabolism coupling, and the pathophysiology of ischemic renal injury.

Public health relevance
PUBLIC HEALTH RELEVANCE: We anticipate that the proposed studies will not only enhance our specific understanding of the mechanisms of epithelial Na+ channel regulation by the metabolic sensing kinase AMPK in the kidney, but could also suggest novel therapeutic strategies for the prevention and management of renal ischemia, a major cause of acute kidney injury. Acute kidney injury in the setting of ischemia is a major public health concern that causes excess morbidity and mortality in many of our hospitalized patients. These studies may also provide novel insights into the general regulation of cellular AMPK function, which may affect a variety of cell processes, including growth, apoptosis, inflammation, and the control of metabolic pathways with relevance to our understanding of several public health conditions, including cancer, diabetes, heart disease, and obesity. ) __SpecificAimsTextDelimiter__ SPECIFIC AIMS The epithelial Na+ channel (ENaC) is the major entry step for Na+ reabsorption in the distal nephron, airway, and colonic epithelia [1]. Proper function is critical to the regulation of body volume status, blood pressure, and airway fluid balance [1]. ENaC is highly regulated by hormones and other intra- and extracellular stimuli [2] and is inhibited during conditions of metabolic stress (e.g., ischemia or hypoxia) [3, 4]. Our recent work has established that the metabolic sensor AMP-activated protein kinase (AMPK) inhibits the activity of ENaC and other important epithelial transport proteins [5-10], which we hypothesize provides a coupling mechanism between ion transport and cellular metabolic status [11]. The expression and activity of many ion transport proteins are inhibited under conditions of metabolic stress, thereby limiting the dissipation of ionic gradients and preserving the energy required to maintain them [12]. Inhibition of ion transport proteins by AMPK thus appears to be consistent with its known homeostatic role in preserving energy stores by inhibiting cellular energy-consuming processes under conditions of energy depletion, which may occur with tissue ischemia [13]. Recent work by us and others has established that AMPK inhibits ENaC by decreasing its expression at the apical membrane via enhanced endocytosis and ubiquitination through enhanced ENaC binding to Nedd4- 2 [5, 6, 14], an E3 ubiquitin ligase that has emerged as a convergence point for ENaC regulation [15]. Our preliminary data indicate that AMPK directly phosphorylates Nedd4-2 at a site shared by other kinases, and this phosphorylation appears to be critical for cellular Nedd4-2 stability. Additional preliminary data suggest that the Rho-GEF signaling protein β1Pix, which inhibits ENaC by impairing 14-3-3¿ binding to Nedd4-2 thereby promoting Nedd4-2 targeting of ENaC [16], is required for the AMPK-dependent inhibition of ENaC and is an AMPK phosphorylation target in vitro. We thus hypothesize that AMPK exerts two effects on Nedd4-2 to enhance its interaction with and inhibition of ENaC: (1) direct Nedd4-2 phosphorylation by AMPK, which enhances Nedd4-2 stability; and (2) AMPK phosphorylation of β1Pix, which enhances Nedd4-2 association with ENaC by competing with Nedd4-2 for 14-3-3¿ interaction (Cf. Fig. 1). Further preliminary data suggest that AMPK contributes to the acute inhibition of ENaC with chemical ischemia in polarized cortical collecting duct (mpkCCDc14 cells) and that ENaC expression in the kidney is upregulated in vivo in an AMPK- α1 knockout model with largely kidney-specific loss of AMPK function [17]. We thus further hypothesize that AMPK regulation of ENaC is relevant in vivo and that AMPK activation plays an important role in Na+ transport inhibition following renal ischemic injury in vivo. The proposed studies should promote our understanding of the mechanisms of transport-metabolism coupling by AMPK and the pathophysiology of ischemic renal injury, and could suggest potential novel therapeutic strategies to ameliorate kidney damage following ischemic injury. To evaluate the mechanisms of AMPK-dependent ENaC regulation via Nedd4-2 and test its role in ischemic kidney injury in vivo, we propose the following three Specific Aims: Specific Aim 1: Examine the role of Nedd4-2 phosphorylation by AMPK in the AMPK-dependent regulation of ENaC and Nedd4-2 stability. We hypothesize that AMPK phosphorylation at the major site of Nedd4-2 is physiologically relevant in vivo, is required for the regulation of ENaC by AMPK, and is a key determinant of Nedd4-2 protein stability in cells. In Aim 1A we will examine whether phosphorylation of Nedd4- 2 by AMPK at the major site occurs in kidney cells and tissues in vivo using a phospho-specific antibody to probe phosphorylation at this site in cells and tissues. In Aim 1B we will test the role of phosphorylation at the Nedd4-2 major site in the regulation of ENaC by AMPK in oocytes and mpkCCDc14 cells. In Aim 1C we will examine the mechanisms of Nedd4-2 stability and the cellular pathway for its degradation by investigating wild- type and mutant Nedd4-2 ubiquitination and proteasomal degradation. Specific Aim 2: Examine the role of AMPK phosphorylation of β1Pix in the regulation of ENaC. In Aim 2A we will confirm the involvement of β1Pix in the regulation of ENaC by AMPK through patch-clamp studies. In Aim 2B we will examine AMPK-dependent phosphorylation of β1Pix in intact cells and identify the site(s) of AMPK phosphorylation in β1Pix by mass spectrometry approaches. In Aim 2C we will examine whether changes in AMPK activity and phosphorylation of β1Pix modulate β1Pix- and Nedd4-2-dependent protein- protein interactions in cells. In Aim 2D we will examine whether AMPK phosphorylation of β1Pix is required for the AMPK-dependent regulation of ENaC via β1Pix through patch-clamp studies with expression of phosphorylation site mutants of β1Pix. Specific Aim 3: Examine the role of AMPK in the down-regulation of ENaC in vivo in response to acute ischemic kidney injury. In Aim 3A, we will test the role of AMPK in the down-regulation of ENaC in response to chemical ischemia through patch-clamp measurements performed ex vivo on freshly isolated, split-open kidney collecting ducts from AMPK-α1 KO mice vs. WT littermate controls. In Aim 3B we will examine the role of AMPK in the rapid redistribution of ENaC away from the apical membrane of collecting ducts in these mice following the induction of acute ischemia. We will also test the potential role of prior AMPK activation (to mimic ischemic preconditioning) in the studies proposed in both sub-Aims.